Chemical approaches for precise recognition of a toxic RNA repeat

PROJECT SUMMARY Recent studies of RNA function in both normal and pathophysiological processes have revealed the growing importance of RNA as a drug target. One important class of disease-causing RNAs are RNA repeat expansions which cause greater than 20 neuromuscular disorders including Huntington’s disease (HD) and myotonic dystrophy types 1 and 2 (DM1 and DM2). Discovery of the central toxic agent in these diseases and others has illuminated a novel means to treat them—through targeting the disease-causing RNA to prevent protein binding or translational defects. These RNA repeats have been successfully targeted with both small molecules recognizing RNA secondary structure and antisense oligonucleotides targeting RNA sequence. Although these antisense oligonucleotides can improve disease biology, in many cases they cannot discriminate between the mutant transcript and other RNAs containing shorter non-pathogenic repeats and also suffer from lack of permeability, blood-brain penetrance, and stimulation of immune response. Thus, a major issue that needs to be addressed is how to precisely target only the disease-causing gene in vivo with small molecules that can be easily optimized for selectivity and potency. Herein, I propose to develop novel small molecule approaches to more precisely target the RNA repeat causative of DM1 (r(CUG)exp) in vivo. I have previously shown DM1-associated defects can be corrected in vivo using a small molecule that specifically cleaves r(CUG)exp. To create more potent small molecules targeting r(CUG)exp, I will first expand on an approach which uses a disease-causing RNA as a catalyst for therapeutic synthesis. In this approach, monomeric subunits react upon binding to the disease-causing RNA to form potent multivalent therapeutics, combining the favorable pharmacological properties of small molecules with the potency and selectivity of multivalent oligomers. This method will be optimized to create a rapid RNA-templated fluorogenic click reaction for precise recognition and labeling of r(CUG)exp in vivo. Using this approach in vivo will provide a novel method to potently and selectively target r(CUG)exp and improve DM1-associated defects. To further enhance the precision of small molecules targeting RNA repeat expansions, I will combine these two small molecule approaches and terminate an RNA-catalyzed click reaction with a small molecule cleaver. This approach will create a potent oligomeric cleaver and will greatly reduce the amount of small molecule cleaver needed to destroy r(CUG)exp and improve DM1-associated defects in vivo. These novel small molecule approaches to modulate r(CUG)exp in vivo have broad implications from basic biology to medicinal chemistry. Importantly these methods can be applied to multiple RNA repeat expansions and will greatly impact the way that these disease-causing RNAs are studied and treated.

Public health relevance
PROJECT NARRATIVE RNA repeat expansions cause greater than 20 neuromuscular disorders including Huntington’s disease (HD) and myotonic dystrophy types 1 and 2 (DM1 and DM2). These RNA repeats have been targeted with both small molecules and antisense oligonucleotides, however, one challenge that remains is precise recognition of the mutant transcript to correct disease-associated defects in vivo. The aim of this project is to design two small molecule approaches to potently and selectively target the RNA repeat causative of DM1 in vivo and to advance the methods used to study and treat these RNA repeat expansions.